Research Training in Myocardial Biology at Stanford

DESCRIPTION (provided by applicant): Stanford School of Medicine is a small, research-intensive medical school with a rich history of innovation and translation of biomedical science to the clinic and bedside. This proposal for a training program in translational myocardial biology reflects a multidisciplinary approach to research and education. The faculty are drawn from diverse departments around Campus and represent world renowned experts in their chosen fields. The cohesion of this group, which includes physiologists, molecular biologists, engineers, geneticists, and cardiologists has been fostered by the principal investigators in an environment which has for decades placed a high value on collaboration and which, over the course of the last several years, has been further strengthened through the founding of the Stanford Cardiovascular Institute. Faculty collaborate extensively, sharing lab equipment and techniques, co-mentoring trainees, and meeting quarterly to discuss future collaborations. In addition, the research groups come together weekly for a seminar series. This application seeks to underscore the proven success and productivity of this effort by putting at its center a training program for post doctoral scholars. In particular, the proposal reflects a commitment to rigorous scientific training by protecting a minimum period of three years. The commitment begins with a 'mentored' recruitment process, continues with a comprehensive approach to learning the scientific method, and extends well beyond the completion of the funded period with career development, help and advice to ensure our trainees' success as they enter into full time academic positions. As further testament to our dedication to rigorous training in the scientific method, MD trainees will be given the option to apply for an advanced degree in science (PhD) during which tuition would be paid by the School of Medicine. Our aim is to mentor the next generation of leaders in myocardial biology. Our commitment extends until our trainees fulfill this goal.